Mitochondrial ROS Microdomains and Neuronal Ischemia

Project Summary
Reactive oxygen species (ROS) contribute to pathology, but conversely, in limited measure they can also act as
second messengers, whereby they contribute to beneficial cellular signaling. Similar to calcium signaling or other
second messengers, the precise location, timing, and duration of ROS production likely determine divergent
signaling outputs. The mechanism underlying this functional dichotomy in redox biology is currently under
studied. An intriguing example of an apparent paradoxical impact of ROS occurs at complex I of the mitochondrial
electron transport chain. In the case of detrimental effects of oxidation, mitochondrial complex I ROS production
is mechanistically linked to oxidative damage in ischemia reperfusion (IR) injury, the pathology of stroke. In the
case of beneficial signaling, complex I ROS production is implicated in protective hypoxic signaling. Indeed, the
fact that some ROS production is a normal consequence of mitochondrial respiration supports the idea that ROS
contribute to normal physiology. Therefore, describing the nuances of complex I ROS production and its context-
dependent metabolic effects is necessary to fully determine the mechanisms of mitochondrial redox signaling,
both damaging and physiologic. To achieve that goal, precise experimental control of ROS production is
required. Until recently, controlling ROS production as an independent variable has been difficult. This renewal
leverages an optogenetic approach championed by our lab to overcome this barrier, and isolates ROS production
at complex I in the genetic model organism C. elegans. Previously, we have shown that ROS production at the
complex II microdomain differentially affects redox-sensitive outcomes in models of IR injury, depending on
whether the ROS were produced inside the mitochondrial matrix or in the intermembrane space. Using our
published novel CRISPR/Cas9 technology optimized for rapid use in C. elegans, we will target well-characterized
light-activated ROS generating proteins (RGPs) to endogenous complex I in order to precisely control the
location, timing, and duration of complex I ROS production with light. This will provide a model of either complex
I redox signaling, or oxidative damage, depending on the light-titration of RGP activation, where more light will
produce more ROS. Combined with tissue-specific expression, we will determine the effects of each of these
spatiotemporal parameters on normal mitochondrial function, neuronal function, and stress-resistance signaling
programs in response to simulated IR injury. We will focus on the neuronal outcomes of complex I ROS
production, both in response to strong literature support for the importance of neurons in mediating hypoxic
stress signaling, and to determine neuronal circuits that could be targeted for translation to mammalian models
of stroke. This approach is perfectly suited to the powerful C. elegans genetic system. We expect that completion
of our aims will provide novel, fundamental insights with clear answers to questions about how the mitochondrial
complex I ROS microdomain controls diverse outcomes in both disease and physiology.

Public health relevance
Project Narrative Mitochondrial complex I reactive oxygen species (ROS) production is causally linked to damage in ischemia reperfusion injury, the driving pathology of stroke. Complex I ROS production can also trigger endogenous protective signaling processes, however, and the precise mechanisms governing the physiologic versus the pathologic events are unknown and under studied. We propose to define the mechanisms underlying the apparent duality of ROS by taking unprecedented control of complex I ROS production at a fundamental level to reveal potential mechanisms of damage and recovery in hypoxic pathology.